EPIDEMIOLOGY OF PRIMARY INTRACRANIAL NEOPLASMS

Determine incidence rates for primary intracranial neoplasms by age, sex, ethnic group, and histologic type for the years 1975 through 1980 among the Jewish population of Israel.